Liquid Immunotherapeutic Fiducial Eluter (LIFE) Gel for Cervical Cancer

Current treatment options for advanced cervical cancer are limited, with a 5-year overall survival rate of 17%. Innovative therapeutic approaches for metastatic disease that can increase access are greatly needed. To meet this need, in this project Nanocan Therapeutics Corporation in collaboration with Johns Hopkins University, will develop innovative technology that can extend the use of local radiotherapy (RT) from palliation to distant control of metastatic
cervical cancer with substantially reduced treatment time and cost, facilitating access to care. The new technology, which Nanocan has licensed from the Dana-Farber Cancer Institute at Harvard Medical School is a Liquid Immunotherapeutic Fiducial Eluter (LIFE) gel that can be easily administered locally and works in conjunction with hypo-fractionated radiotherapy for treatment of patients with advanced cervical cancer. Preliminary studies illustrate that the use of the biocompatible/biodegradable LIFE gel technology can cause regression of both treated (local) and distant untreated (metastatic) tumors and enable development of immunologic memory controlling disease over the long term. This Phase II STTR project will fund the first clinical trial to demonstrate safety of the LIFE gel product and treatment protocol. Innovative advantages of the LIFE gel include potential to overcome immunosuppression due to sustained delivery, minimal systemic/overlapping toxicities, simple short treatment regimen, and providing imaging contrast for precision RT. The highest clinical impact of the LIFE gel technology approach is anticipated in significantly improved survival of advanced cervical cancer patients. Preliminary studies also show that this can provide a substantially less expensive alternative to systemic treatment and replace the intensive regimens over months to a brief intervention, which will create
significant opportunities for better cancer care.

Public health relevance
PROJECT NARRATIVE The central innovation and overall goal of this project is the development of new immunotherapeutic smart radiotherapy biomaterial technology (LIFE gel) combining hypo-fractionated radiotherapy (HFRT) with sustained intra-tumoral immunotherapy delivery to boost systemic treatment of metastatic cervical cancer. This project will establish optimal parameters for maximum therapeutic efficacy and safety when using the biocompatible/biodegradable LIFE gel in combination with HFRT. The highest clinical impact of the new approach is anticipated in significantly increasing the survival of metastatic cervical cancer patients and reducing disparities in access to treatment due to decreased treatment time and costs.